Baylor College of Medicine Initiative for Maximizing Student Development

Summary
The Baylor College of Medicine Initiative for Maximizing Student Development (BCM-IMSD) aims to enhance
the training and increase the numbers and success of underrepresented (UR) scientists trained at the
Graduate School of Biomedical Sciences at Baylor College of Medicine. BCM has made significant advances
in educating UR scientists, having graduated more than 13 UR PhDs and MD/PhDs every year for the past 5-
years. Since 1998, 165 under-represented students have received PhDs. Many BCM-IMSD alums have
excellent records of achievement and productivity equivalent to non-UR trainees at BCM, positioning them for
leadership roles in the biomedical research community. Of equal importance, 95% of IMSD-funded and 90% of
all UR alums are currently active in a research-related field. The BCM UR and non-UR alums are becoming
post-docs, residents, and fellows at research-intensive institutions and research-related industries. The overall
goal is to maximize the development and productivity of every UR trainee using activities provided through the
BCM-IMSD to enhance the generation of a top-notch and diverse STEM workforce across the United States.
The IMSD UR students receiving local, national, and international awards have increased dramatically since
1998 to more than 300 awards, including national fellowships. Our alums are progressing in their careers in
science or professions where they use their scientific training. We propose to continue recruiting, retaining, and
graduating UR scientists trained at BCM to diversify the biomedical workforce by focusing their minds on
innovative approaches and experiences to build knowledge to decrease morbidity and mortality and improve
the health of our diverse national population. We will enhance UR graduate education by supporting students'
technical, operational and professional skills development to work at state-of-the-art research laboratories and
core facilities at BCM. We will use evidence-informed educational and mentoring practices to build an
inclusive, safe and supportive research environment, provide community building, and recruit faculty trained in
culturally aware mentoring, Entering Mentoring (and Entering Research for students) established by the
National Mentoring Research Network. The BCM-IMSD activities that will increase retention and decrease time
to a degree include: building a supportive community, tutoring, academic success workshops, faculty and peer-
to-peer mentoring, writing workshops, scientific conference participation, support for fellowship writing and
grantsmanship, acquiring teamwork skills through team-based science series developed at BCM, and
innovative educational experiences to support the development and career management for student success.

Public health relevance
Project Narrative: The Baylor College of Medicine Initiative for Maximizing Student Development (BCM- IMSD) will mentor underrepresented graduate students (UR) in science and medicine to be successful in research-intensive biomedical Ph.D. programs and pursue research and research-related careers. The training includes support for mentoring, original research in a laboratory, science writing and oral presentation skills, analysis of the scientific and medical literature, critical thinking and evaluation, responsible research conduct, and scientific rigor and reproducibility principles. The BCM-IMSD student scholars will develop knowledge and experience in foundational science and clinical and translational research, ask critical questions supplemented with mentorship and training in leadership, teamwork, and communication skills that foster confidence and independence, and serve as role models for UR students, colleagues, and the broader diverse communities about biomedical research and healthcare.